Novel immunotherapies using optimized tumor cell-penetrating antibodies

ABSTRACT
Using recombinant antibodies targeting common oncogenic mutations, we have recently
demonstrated that dimeric IgA penetrates human epithelial cancer cells through PIGR-dependent
transcytosis, neutralizing mutated oncodrivers and expelling them outside the tumor cell.
Accordingly, targeting KRASG12D with dimeric IgA abrogated the growth of different carcinomas.
Moving forward, our primary objective is to translate tumor cell-penetrating Abs into the clinic.
However, challenges arise due to the low yield associated with dimeric IgA production and the
comparatively extended half-life of IgG antibodies. To expedite clinical translation and maximize
therapeutic effectiveness, we have engineered new IgG4 antibodies incorporating a PIGR-binding
peptide at the C-terminus of the Fc domain. PIGR-binding IgGs penetrate cancer cells and elicit
Ag-specific control of tumor growth. Our central hypothesis is that our mutant KRAS-specific
recombinant IgGs control KRAS-driven carcinomas that became resistant to small molecule
KRAS inhibitors, with longer half-lives and production yields than recombinant dIgA, while making
tumor cells sensitive to T cell-mediated killing. This hypothesis will be tested in these Aims:
In Specific Aim 1, we will elucidate the mechanisms governing the effectiveness of our
new PIGR-binding mutation-specific IgGs. Besides understanding how these Abs neutralize
antigenic mutations inside tumor cells, we will select a candidate for clinical development, based
on effectiveness, the capacity to target multiple mutations, and production yields.
In Specific Aim 2, we will define how transcytosis of PIGR-binding IgG impacts T cell-
dependent anti-tumor immunity. We will define mechanistically-driven and safe interventions that
synergize with PIGR-binding Abs, possibly including immune checkpoint inhibitors.
In Specific Aim 3, we will determine whether tumor cell-penetrating Abs overcome
resistance to inhibitors across various mutations. We will establish a range of human cancers
sensitive to our new immunotherapy, including tumors that became resistant to inhibitors.
These studies will not only bridge existing knowledge gaps regarding transcytosing antibodies,
but also pave the way for a new generation of immunotherapies that effectively combat aggressive
human cancers driven by mutational hotspots, and perhaps other cytosolic proteins.

Public health relevance
PROJECT NARRATIVE Although immunotherapy has revolutionized the management of cancer patients, most tumors remain poorly responsive to existing immunotherapies. The proposed studies will define a new class of immunotherapy using tumor cell-penetrating antibodies, with the capacity to target intracellular oncodrivers. These studies will provide a mechanistic rationale for ensuing clinical trials designed to abrogate the progression of thousands of human cancers driven by common mutational hotspots in oncogenes.